Probiotic-derived nano-particles in alcoholic liver disease

Probiotics have been used to prevent/treat alcoholic liver disease (ALD). Live probiotics need to colonize the gut
to exert their function. Unfortunately, underlying disease states provide an unfavorable environment for probiotic
bacterial gut colonization, which diminishes probiotics’ function. In the last few years, we showed that LGG
culture supernatant (LGGs, without live bacteria) was effective in the prevention of ALD in experimental models
of acute and chronic alcohol exposure in mice. However, how LGG supernatant exerts its therapeutic effects is
not fully understood. Exosomes are nanoparticles (NPs) derived from cell endocytosis which act as transmitters
between cells. Recent studies show that bacteria, both Gram-negative and Gram-positive, produce NPs. The
NPs derived from “bad” bacteria have been demonstrated to be pathogenic. However, “good” bacteria-,
probiotics-derived NPs have not been studied. Our preliminary study showed that administration of LGG-derived
exosome-like NPs (LDNPs) effectively reversed ALD in the binge-on-chronic alcohol exposure mouse model,
suggesting that probiotic LGGs may exert its function through LDNPs in ALD. Administration of LDNPs markedly
increased intestinal AhR activity, IL-22, and regenerating islet-derived 3 (Reg3) β and γ expression, which play
a key role in maintaining gut microbiota homeostasis and preventing bacterial intestinal transcytosis. In addition,
LDNPs administration significantly increased intestinal epithelial cell (IEC) tight junctions and decreased
circulating LPS concentration associated with upregulation of intestinal Nrf2 signaling, which is known for
protecting intestinal barrier junctions against oxidative stress-induced damage by alcohol. Metabolomic analysis
revealed that LDNPs contain high levels of microbial metabolites of tryptophan, which are AhR ligands, indicating
LDNPs may activate intestinal AhR signaling. Furthermore, we demonstrated that ginger exosome-like
nanoparticles (GDNPs) are preferentially taken up by LGG, suggesting that GDNP may serve as a prebiotic to
enhance the effects of LGG. These preliminary studies provide the groundwork for our central hypothesis that,
by activating intestinal AhR-Nrf2 signaling, LDNPs increase intestinal expression of Il-22, Reg3 and tight
junctions, and modulate gut microbiota homeostasis and enhance intestinal barrier function, leading to the
suppression of ALD. We will test our hypothesis in following four specific aims: (1) Determine the role of bacteria-
derived NPs in ALD; (2) Define the mechanisms of the beneficial effects of LDNPs in ALD; (3) Determine whether
GDNPs treatment enhances LDNP production and AhR agonist enrichment that lead to improved effects of
LDNPs against ALD; and (4) Evaluate the intestinal AhR-Nrf2 signaling in alcoholic hepatitis patients treated with
LGG. Completion of this study is expected to significantly impact the development of LGG-based probiotic
therapeutics in the treatment of alcohol-associated liver diseases.